An Open Learning Disabilities Behavioral Data Repository

PROJECT SUMMARY
There is considerable interest in data sharing, encouraged by funding agencies which are requiring more
detailed data-sharing plans, as well as greater attention and support from the scientific community towards
rigorous, open, and reproducible science. With this project, we will build a domain-specific data repository,
“LDbase”, containing behavioral data from the field studying learning disabilities that will serve as a
powerful resource for our community. We are uniquely qualified to build this repository. Our investigator
team combines expertise in learning disabilities, advanced methodology, and research librarian techniques.
LDbase will accelerate intellectual discovery by facilitating data reuse and reproducibility, ultimately building
an enduring record that represents the richness, diversity, and complexity of the science done by learning
disabilities researchers. We will achieve this through three specific aims: (1) Create a data repository
representing a vast knowledge database on learning disabilities; (2) Release a powerful open access
combined dataset and provide statistical training for combining datasets using integrative data analysis; and
(3) Use integrated data to determine the most valid way to classify a reading disability for each child.
LDbase will be seeded by data from six large research sites that will contribute large amounts of behavioral
data from tens of thousands of participants, and then open to external data depositors and data users. With
these high quality “big data”, we will answer a fundamental question in the field concerning personalized
classification of reading disability, showing the powerful applied usefulness of these data. LDbase will
advance the sharing of learning disabilities related behavioral data as a powerful new tool to answer
research questions not answerable without it, build a community of researchers invested in data sharing
and open science practices, and establish a sustainable infrastructure to support the longevity of the
project.

Public health relevance
PROJECT NARRATIVE Behavioral data related to learning disabilities is expensive and difficult to collect, typically requiring extensive federal investment to get appropriately powered samples. Sharing data from these samples will propel creative new research questions for a small additional investment, and enhance the learning disabilities field and its engagement with the public. Sharing data is especially important for promoting public health as it drives innovation in science, and here we spur innovative research for children in schools.